Maternal ZIKV infection as an environmental risk factor for mental illness

Abstract
A large body of evidence has identified maternal immune activation following viral infection as an
environmental risk factor for mental illness. Maternal immune signals, including inflammatory cytokines, can
access fetal tissues and permanently alter brain function and behavior in otherwise developmentally normal
offspring. Indeed, maternal infection with a number of viruses has been associated with the development of
mood disorders and/or psychosis in offspring, and these associations are intensified in offspring with
preexisting genetic risk factors for mental illness. Zika virus (ZIKV) is an emerging pathogen recently
identified as an etiologic agent of severe neurodevelopmental syndromes following infection during the early
stages of gestation. However, the impacts of maternal ZIKV infection during late gestation have not been
adequately addressed, nor has the potential impact of maternal ZIKV infection on the mental health of
developmentally normal offspring been investigated. Here, we propose to use a murine model of late-term
maternal ZIKV infection to characterize neuroimmune signaling at the maternal-fetal interface. To study the
consequences of this signaling, we will also assess the impact of late-term maternal ZIKV infection on the
development of behavioral abnormalities in motor, cognitive and social domains that underlie psychiatric
disorders (e.g., autism, schizophrenia). Finally, we will use an established mouse model of human 22q11.2
deletion syndrome, a common genetic susceptibility factor for mental illness, to examine interaction effects
of maternal ZIKV infection with genetic risk for behavioral abnormalities. These studies will establish the
potential pathologic behavioral consequences of late-term ZIKV infection, informing future study and
monitoring efforts for individuals affected by this globally emerging pathogen.

Public health relevance
Project Narrative This project aims to define the neurodevelopmental and behavioral consequences of maternal Zika virus infection during late pregnancy. We will develop and implement a new mouse model of late-term maternal Zika virus infection in order to identify previously unknown links between maternal antiviral immunity and behavioral dysregulation in offspring.